Developing novel CRISPR/CasX editors to generate a CCR5/null immune system

The characterization of CRISPR/Cas as a method to edit genes that contribute to human diseases
provides new opportunities for the development of innovative therapeutic approaches. Seven years ago, this
bacterial immune system was adapted to cleave specific regions in the human genome. Currently, there are
over a dozen clinical trials planned or in process for cancer, genetic disorders and infectious diseases that
utilize CRISPR editing. Moreover, gene editing can be used to cleave and potentially excise viral genomes
within infected cells, which offers hope for curative strategies for HIV-1 and hepatitis B infections, as well as
others. The majority of pre-clinical and clinical studies use the Cas9 enzyme derived from common human
pathogens, and evidence for the existence of humoral and cellular immunity to Cas9 could stymie the utility of
this editor in a subset of patients, especially if delivered in vivo using viral vectors, or if therapy requires
repeated infusions (1, 2).
These and other limitations of the family of Cas9 endonucleases argue for the development of a more
diverse toolbox of gene editing enzymes. Recently, several novel Cas enzymes termed CasX (Cas12e) and
CasY (Cas12d) were identified in metagenomic sequencing data from environmental isolates (3), and we are
actively developing these enzymes for gene editing. The advantages of these enzymes include their derivation
from non-pathogenic bacterial species, their relatively compact size compared to Cas9, and their distinct
protospacer adjacent motif (PAM) requirements. The cut generated by the guide RNA/CasX ribonucleoprotein
complex is asymmetrical and generates single stranded DNA overhangs. This unique cleavage cut could then
be leveraged to excise a target region by employing two different guide RNAs that flank the area of interest. By
careful selection of guide RNAs, we expect that we can generate DNA overhangs on opposite DNA strands
that are complementary to each other so they anneal during DNA repair, essentially excising the intervening
region. In addition, we expect that these asymmetrical overhangs can also be used to anneal to an
exogenously supplied donor DNA fragment, so that the excised region is replaced by new DNA sequence.
Our proposed studies will develop CRISPR/CasX to replace the wild-type CCR5 gene with the CCR5-
delta 32 allele in hematopoietic stem cells (HSC) as a next generation approach to the development of a
therapeutic application for HIV-1. It is well established that cells from individuals who are homozygous for the
CCR5-delta 32 allele are resistant to R5-tropic HIV infection, and generating autologous HSCs carrying two
copies of this mutation could potentially allow the permanent cessation of anti-retroviral therapy. To
accomplish this goal, we will develop combinations of guide RNAs to excise the CCR5 gene, and replace it
with donor DNA carrying the mutant allele. Next generation sequencing approaches (CIRCLE-seq, MTA-seq)
will be used to assess the relative efficiency and specificity of CasX both in vitro and in cells. An RNA beacon
will be used to select for cells in which both CCR5 alleles are replaced. Finally, various proportions of wild-type
and CCR5-delta 32-modified HSCs will be used to humanize immunodeficient mice. Mathematical modeling
will define the minimum number of edited HSCs necessary to produce normal numbers of immune cells
following HIV-1 challenge. Ultimately, our approach will lead to the development of novel Cas editors to replace
cellular genes required for HIV-1 infection with those that impart HIV resistance.

Public health relevance
HIV-1 infects cells by binding to the CD4 and the CCR5 receptors on target cells. If a cell lacks either receptor, it is unlikely that it can be infected by most strains of HIV-1. Interestingly, some individuals have a mutation in the gene that encodes the CCR5 receptor, and are unable to become infected with certain strains of HIV-1. Developing methods to induce this mutation, called the CCR5-delta 32 mutation, in the stem cells of HIV-1 infected patients who do not have the mutation would potentially allow them to stop taking anti-retroviral medications without suffering any negative effects. We propose to develop a method that replaces the normal CCR5 gene with one carrying the CCR5-delta 32 mutation into stem cells using a newly discovered enzyme called CasX. We will also determine how many stem cells carrying two copies of the mutation are needed for an HIV-1 patient to stop taking anti-retroviral medications and still maintain a healthy immune system.